Dissecting Mechanism of Neurofibromin Regulation in the Context of Sporadic Cancers and Neurofibromatosis Type 1

Mutations affecting proteins in the RAS pathway have been found in 46% of patient samples, more than any
other signaling pathway. The RAS GTPase activating protein neurofibromin is a crucial component of this
pathway, with mutations in this protein leading to both sporadic cancers and the tumor predisposition syndrome
Neurofibromatosis Type I (NF1 ). Despite its crucial role in modulating RAS activity, little is known about how
NF1 gene expression or its function as a regulator of RAS is controlled by the cell. To investigate this crucial
mechanism, we propose using high-throughput genetic screens to identify novel regulators of the
neurofibromin-KRAS interaction in both healthy and cancerous cells, which could serve as therapeutic
targets for both sporadic cancers and patients with NF1. To do so, we will utilize a novel protein-protein
interaction assay to directly measure neurofibromin-KRAS binding in the context of genetic perturbations
created through CRISPRi and CRISPRa technologies. We will then use biochemical, pharmacological, and
physiological assays to determine the exact mechanism behind these regulators. This work represents the
first example of high-throughput, unbiased genetic screens being applied to neurofibromin regulation
and thus will fill a crucial gap in our understanding of neurofibromin and its role in controlling RAS
signaling. Furthermore, this project has been tailored to provide me the training, knowledge, and
resources I need to establish my independent research career at the interface of cancer biology and
gene therapy.

Public health relevance
This proposal aims to identify novel regulators of neurofibromin-mediated RAS signaling, which when absent, leads to the development of sporadic cancers and the tumor predisposition syndrome Neurofibromatosis type I. This work will not only further our understanding of this complex mechanism but may also identify novel interactions that could be therapeutic targets.